Developing a Post-carcinogen Lung Cancer Chemopreventive Agent

DESCRIPTION (provided by applicant): Since former smokers are at an elevated risk to develop lung cancer and about half of all new lung cancer incidences are among former smokers, there is an urgent need to develop safe and efficacious chemopreventive agents to help former smokers control this deadly disease. Our long-term goal is to develop a Complementary and Alternative Medicine (CAM) modality based on natural food and beverages that will help former smokers to prevent or delay lung cancer development. The results of our recent studies strongly support the notion that kava, a long-standing beverage in the South Pacific Islands, is promising to prevent post-carcinogen lung cancer development, potentially through suppressing NF-kB activation. Our preliminary data also suggest that kava's chemopreventive efficacy can be improved by enriching its chemopreventive constituents. Such optimization may also lead to improved safety. The objectives of this application, therefore, are to improve kava's post-carcinogen chemopreventive efficacy, to establish chemopreventive kava's safety, to identify the origin of potential hepatotoxicity associated with commercial kava, and to explore the mechanisms, such as NF-kB inhibition, that are responsible for kava-induced chemoprevention. Specifically, the following four Aims will be pursued: Aim 1. Determine the post-carcinogen chemopreventive efficacy of kava fractions against lung adenoma formation and establish the efficacy of the most chemopreventive fraction to inhibit lung lesion progression to adenocarcinoma Aim 2. Identify the origin of hepatotoxicity associated with commercial kava Aim 3. Characterize major chemicals in the most chemopreventive kava preparation for QC/QA of the future chemopreventive kava product Aim 4. Determine the effects of the most chemopreventive kava preparation on key signaling pathways, including the NF-kB pathway Upon accomplishing these aims, we will have (a) identified a kava preparation more efficacious and safer than the existing commercial product, (b) established its efficacy to prevent lung cancer progression to adenocarcinomas, (c) ascribed the origin of hepatoxicity associated with commercial kava to the non-polar fraction; (d) characterized active/signature chemicals for better QC/QA of the future kava product; and (e) provided mechanistic insights concerning key signaling pathways and possibly the molecular targets for kava-induced post-carcinogen lung cancer chemoprevention.

Public health relevance
PUBLIC HEALTH RELEVANCE: Lung cancer is the leading cause of death among all malignancies. Former smokers are at a high risk to develop lung cancer. This research focuses on identifying a kava-based safe CAM modality that can prevent NNK/B[a]P-induced lung tumorigenesis in A/J mice with post-carcinogen regimen, the outcome of which is expected to set the foundation for developing a chemopreventive CAM modality that will help former smokers to prevent/delay lung cancer. Project Narrative Lung cancer is the leading cause of death among all malignancies. Former smokers are at a high risk to develop lung cancer. This research focuses on identifying a kava-based safe CAM modality that can prevent NNK/B[a]P-induced lung tumorigenesis in A/J mice with post-carcinogen regimen, the outcome of which is expected to set the foundation for developing a chemopreventive CAM modality that will help former smokers to prevent/delay lung cancer. __SpecificAimsTextDelimiter__ A. Specific Aims Our long-term goal of this research, in response to PA-09-010 (Basic and Preclinical Research on Complementary and Alternative Medicine), is to develop a safe and efficacious Complementary and Alternative Medicine (CAM) modality, based on natural food and beverages, that will help former smokers prevent/delay the development of potentially fatal lung cancers, thereby improving their quality of life. Results of our recent studies, supported by an NIH grant - R03CA125844 (PI: Xing), demonstrate that oral consumption of a well-standardized commercial kava significantly suppresses 4-(methylnitrosamino)-1-(3- pyridyl)-1-butanone (NNK) and benzo(a)pyrene (B[a]P) induced lung adenoma formation in A/J mice in a dose- dependent manner. It suppresses such tumorigenesis in a post-carcinogen regimen, with efficacy better than candidates currently in clinical trials. Kava inhibits NNK/B[a]P-induced NF-:B activation in lung adenomas and suppresses lipopolysaccharide (LPS)-induced NF-:B activation in vivo, a mechanism potentially responsible for its chemoprevention. Fractionation of commercial kava leads to a polar fraction with enhanced NF-:B inhibitory activity. Such a fraction potently suppresses human lung cancer xenograft growth, which could be more chemopreventive than the commercial product. We also identified a non-polar fraction with no NF-:B inhibitory activity and induces toxicity to the liver, potentially responsible for commercial kava's hepatotoxicity. We therefore hypothesize that commercial kava can be fractionated into a safe polar preparation that is highly chemopreventive for post-carcinogen-induced lung cancer, and a non-polar preparation that is hepatotoxic and non-chemopreventive. We further hypothesize that the chemopreventive fraction inhibits several crucial proliferation and survival signaling pathways, such as NF-:B, to mediate its preventive activity. We propose to test our hypotheses by accomplishing the following four Specific Aims: Aim 1. Determine the post-carcinogen chemopreventive efficacy of kava fractions against lung adenoma formation and establish the efficacy of the most chemopreventive kava fraction to suppress lung lesion progression to adenocarcinoma Our working hypothesis is that kava's chemopreventive efficacy can be improved by enriching its active constituents, potentially those with NF-:B inhibitory activity. This hypothesis will be tested in the A/J mouse lung tumorigenesis models. Aim 2. Identify the origin of hepatotoxicity associated with commercial kava Our working hypothesis is that the non-polar constituents in commercial kava are hepatotoxic. We will evaluate the toxicity of kava fractions on hepatocytes from mice, rats, monkeys, and humans. We also will evaluate the safety of these fractions in female F344 rats, an animal model where commercial kava induced hepatotoxicity. Aim 3. Characterize the major chemicals in the most chemopreventive kava fraction Identifying major chemicals and determining their abundance will be crucial information for effective quality control/assurance (QC/QA) of future kava products. Aim 4. Determine the effects of the most chemopreventive kava fraction on key signaling pathways Our working hypothesis is that chemopreventive kava inhibits post-carcinogen lung turmorigenesis through suppressing the NF-:B pathway. We will evaluate the in vivo NF-:B inhibitory activities of kava fractions to establish their relationship with their adenoma preventive efficacies. If they correlate, we will have provided additional compelling evidence to support this pathway being crucial that warrants further validation. Other pathways and targets suggested by our in vitro studies, including STAT3, AP-1, cSrc and IKKβ, will be investiagted as well. Specifically, lung tissues from experiments in Aim 1 will be used for lead identification. Lung tissues from A/J mice with varied durations of carcinogen/chemopreventive kava exposure will be studied for validation and temporal sequence determination (possibly cause-effect relationship). Lastly, we also will identify the protein(s) that chemopreventive compound(s) directly interact with, if time and resources allow. Upon accomplishing these aims, we expect to have (a) identified a kava preparation more preventive against post-carcinogen lung cancer development and safer than the existing commercial product, (b) established its efficacy in preventing lung cancer progression to adenocarcinomas, and (c) ascribed the origin of hepatoxicity associated with commercial kava to a non-polar non-chemopreventive fraction. We will have (d) characterized active/signature chemicals in chemopreventive kava preparation for effective QC/QA of future kava products, (e) provided mechanistic insights concerning key signaling pathways, and (f) possibly identified molecular targets. We are well prepared to undertake the proposed work because of our multidisciplinary expertise in lung cancer chemopreventive evaluation (Xing and Hecht), medicinal chemistry (Xing), cancer biology (L¿), pathology (O'Sullivan), and toxicology (O'Sullivan).